Clinical Project 1: Longitudinal Natural History Study of Syndromic Craniosynostosis

ABSTRACT: CLINICAL PROJECT 1
Syndromic craniosynostosis (CS) encompasses a set of rare diseases characterized by premature ossification
of the cranial sutures, leading to cranial vault distortion and constriction of the growing brain in pediatric
patients. While CS syndromes have become more genetically defined, much remain unknown about how
pathogenic variants correlate with natural history of CS. The Advancing Craniosynostosis Treatment (ACT)
Rare Diseases Consortium establishes a multi-institutional collaboration between leading craniofacial centers
to address key gaps in knowledge for syndromic CS natural history and clinical management. In Clinical
Project 1 (CP1), we will describe the longitudinal natural history for 5 types of CS syndromes: Apert, Pfeiffer,
Crouzon, Muenke and Saethre-Chotzen. This proposal tests the central hypothesis that multi-modal
integration of longitudinal genomic, morphometric, neurocognitive, psychological, and patient reported data will
yield a comprehensive understanding of the natural history that will predict disease progression and response
to treatment for syndromic CS patients. This study will be the largest and most comprehensive prospective
multi-site study of syndromic CS to date, with the following aims: 1) utilize deep phenotyping, molecular
diagnosis, and multi-modal integration with the electronic medical record to characterize syndromic CS
progression over time, 2) evaluate the neuro-cognitive and psychosocial outcomes of syndromic
craniosynostosis and correlate outcomes with clinical history and 3) collect FACE-Q and FACE-Q Kids with a
patient-reported outcomes dashboard that can be used across all patients with syndromic CS. Together, this
study will integrate multi-modal objective measures to correlate genotype to phenotype in the 5 CS syndromes.
CP1 will validate methodologies and provide the context with which medical and surgical treatments can be
objectively measured. The broad impact of this work is to generate the foundational data that will inform future
clinical studies and trials that will establish clinical standards and best practices that will enhance health
outcomes, determine best practices, and ultimately enhance health outcomes for syndromic CS patients.